Oprk1-regulated neurocircuitry and phenotypes of alcohol use disorder

Project Summary. A fundamental characteristic of alcohol use disorders is the loss of control over
alcohol consumption that results in progressively escalating levels of alcohol use and facilitates the
progression to alcohol-dependence. Given the comorbidity of alcohol dependence and disorders of affect
such as depression is extremely high, it has been posited that self-medication of negative affective states
contributes to continued excessive alcohol use and relapse. Furthermore, negative affective states
produced by chronic alcohol exposure can influence the neurocircuitry of cognitive control systems to
perpetuate further excessive alcohol use. Once that degree of dysregulation is reached, components of
the dependence cycle serve to facilitate each other in a manner that is extremely deleterious to personal,
familial and societal welfare. The principal investigator’s long-term goal is to identify effective
therapeutic targets and strategies for the treatment of alcohol use disorder (AUD). The objective of this
application, which is the next step in pursuit of that goal, is to understand the neuroadaptations in Oprk1
(kappa-opioid receptor gene)-regulated systems that occur in response to chronic alcohol exposure and
contribute to maladaptive behavioral regulation. The central hypothesis is that the Oprk1-regulated
neurocircuitry becomes progressively dysregulated in a manner that promotes the continued excessive
consumption of alcohol and perpetuates the cycle of alcohol dependence. The rationale for the proposed
studies is that understanding the contribution of dysregulated Oprk1 expression in AUD will lay the
foundation for the development of effective therapies designed to alleviate maladaptive behavioral
regulation produced by alcohol dependence. This hypothesis will be tested by utilizing inducible and
conditional CRISPR/CAS9 gene editing and chemogenetic approaches to recapitulate or ameliorate
symptoms of alcohol dependence in non-selected and transgenic rats. Animal models of operant alcohol
self-administration, negative affective-like behavior and executive function including working memory
will serve as functional end-points to systematically investigate the role of Oprk1 expression in
maladaptive behavioral regulation related to alcohol dependence. In addition, Oprk1 gene expression will
be assessed as a complement to the behavioral approaches. The proposed research will help to identify
the functional importance of neuroadaptations in Oprk1-regulated systems that result from chronic
alcohol exposure and will provide much needed information regarding the influence of Oprk1 on the
neurocircuitry of AUD-related phenotypes. Such a contribution is significant because it will help identify
and develop therapeutic targets to treat AUD that focus on the removal of maladaptive phenotypes; a
strategy that should greatly increase treatment compliance and decrease rates of relapse.

Public health relevance
Project Narrative. This proposal is relevant to public health and will have an important positive impact because there are currently no therapeutic strategies designed to alleviate negative affective states and cognitive dysfunction that accompany alcohol dependence and withdrawal and persist into protracted abstinence to promote excessive alcohol consumption. The benefits of the current proposal are the inducible and conditional genetic as well as chemogenetic manipulation of kappa-opioid receptor systems in combination with comprehensive behavioral phenotyping in motivational, negative affective and executive function domains. This research should provide a foundation for personalized therapeutics designed to reduce maladaptive behavioral regulation in alcohol dependence.